Mediterranean Diet and Weight Loss: Targeting the Bile Acid/Gut Microbiome Axis to Reduce Colorectal Cancer Risk

ABSTRACT. Colorectal cancer (CRC) is associated with multiple risk factors including, obesity, low fiber diets,
and diets high in animal protein and saturated fat (SFat). African Americans (AAs) have a higher prevalence of
these risk factors and they have the highest incidence of CRC and related mortality. These multiple risk factors
are also linked to higher circulating and fecal bile acids (BA) and a shift in BA amino acid conjugation from glycine
to taurine. These BA-related changes can alter the composition, structure, and metabolic activity of the gut
microbiota, fostering conditions for gut bacteria to expand and metabolize taurine-conjugated BAs to genotoxic
hydrogen sulfide (H2S) and the tumor promoter, deoxycholic acid (DCA); a colonic milieu conducive to the
formation of CRC. We have shown that the abundance of H2S-producing bacteria is significantly higher in the
colon of AAs compared to non-Hispanic whites and is a defining feature among AA CRC cases implicating these
bacteria as contributors to CRC development in a race-dependent manner. Moreover, the microbial difference
is associated with higher intake of SFat and animal protein in AAs, providing a pivotal intervention target. We
hypothesize that targeting the BA-gut microbiome axis to suppress abundance, growth and metabolic activity of
H2S and DCA producing bacteria through diet and weight loss (WL) may reduce CRC risk, especially among
AAs. A Mediterranean Diet (MedDiet), a largely plant-based dietary pattern, is relevant to CRC prevention and
microbial production of anti-cancer metabolites in observational studies. A MedDiet can shift BA metabolism as
shown in primates and when combined with calorie restriction, shows superior adherence and weight control in
humans, given its palatability. To date, no studies have tested in an RCT the effects of a MedDiet alone (Med-
A), WL through lifestyle intervention (WL-A) or a calorie-restricted MedDiet for WL (WL-Med) on the BA-gut
microbiome axis and its relevance to CRC prevention among AAs. Our multidisciplinary team combining
expertise in psychology, nutrition, microbiology, molecular cell biology, computational biology, medicine and
biostatistics, propose to conduct a four-arm RCT in which 200 obese AAs, 45-75 years old complete one of the
following 8-month interventions: Med-A, weight stable; WL-A, calorie restriction with no diet pattern change; WL-
Med; or Control. We will use samples and data collected at baseline, mid-study (month-4) and post-intervention
to compare the effects of the interventions on 1) Concentration and composition of circulating and fecal BAs; 2)
Gut microbiota and metabolic function; and 3) Gene expression profiles of exfoliated intestinal epithelial cells.
Our approach is strong given our multidisciplinary team, use of evidence-based lifestyle interventions, and
sophisticated –omics analyses to examine crosstalk between diet/WL, gut microbiome, and host intestinal
physiology. If successful, this study could have profound public health impact on CRC risk among AAs and other
high-risk populations, that would translate into timely dissemination opportunities.

Public health relevance
PROJECT NARRATIVE African Americans (AAs) have the highest colorectal cancer (CRC) incidence and mortality that we hypothesize can be attributed to their higher prevalence of obesity, intake of low fiber, high animal protein and saturated fat diets and a higher abundance of gut bacteria known to metabolize bile acids to metabolites that are genotoxic and tumor promoting. Obesity and diet determine the extent to which bile acid metabolism is a risk factor for CRC. This proposal will determine if the largely plant-based Mediterranean Diet alone, weight loss alone or the two interventions combined can affect the bile acid-gut microbiome axis ultimately revealing critical information on how weight loss and diet can address CRC risk in AAs, but also in other high-risk populations.